Defining tissue specific phenotypes that faithfully identify tissue resident memory T cells

ABSTRACT
CD8 T cells control live replicating viral infections, but most licensed vaccines do not efficiently generate
protective memory CD8 T cells. Recent evidence suggests that developing vaccines that establish memory CD8
T cells may be the solution to controlling or preventing historically recalcitrant pathogens. Tissue-resident
memory CD8 T cells (TRM), which occupy many tissues of the body without circulating and persist long term,
have a vital role in tissue immunosurveillance. TRM are also increasingly thought to mediate allergic and
autoimmune responses and transplant rejection. TRM were only recently discovered, and thus there are
substantial gaps in our understanding of the mechanisms by which TRM achieve anti-viral immunity and contribute
to immunopathology. If future vaccination and therapy strategies are to successfully leverage CD8 TRM for
protection against pathogens or reducing immunopathology, fundamental questions on how TRM are generated
and maintained in tissue need to be addressed. I recently compared the transcriptional programs of TRM
populations with recirculating T cell subsets and CD8 T cell populations that transiently express the imperfect
TRM marker CD69 in response to recent TCR stimulation or inflammation. I also developed an original approach
and workflow to identify tissue specific TRM phenotypes. Through Aim 1 I will further expand our knowledge of
shared and tissue specific CD8 TRM transcriptional and phenotypic signatures. I will also validate tissue specific
phenotypes via flow cytometry, parabiosis studies, and the use of `dirty' mice that contain CD69+ T cells within
the equilibrating T cell population. Through Aim 2 I will apply a CRISPR/Cas9 gene editing approach that I have
established to evaluate the role of several exhaustion genes in the ontogeny, differentiation and maintenance of
TRM. Further elucidation of how tissue-resident memory T-cell populations are generated and maintained in
peripheral tissues and the role they play in immune responses in tissue will assist in the design of prophylactic
vaccines and may also inform the development of therapies that treat intractable infections or disease.

Public health relevance
PROJECT NARRATIVE Despite significant advances in our understanding of the vital role of tissue-resident memory T cells in immune responses, fundamental questions about the mechanisms by which TRM are generated and maintained in tissues undermine successfully finding effective solutions to overcome many intractable diseases. The objectives of this proposal are to define tissue specific TRM phenotypes and to assess the role of several genes associated with exhaustion in the differentiation and maintenance of TRM. Results will have a direct impact on designing strategies to promote or modulate TRM which will have broader implications as to how TRM effect pathogen protection, tumor control, and autoimmune pathogenesis.